HIGHLY SELECTIVE MACROBIOMOLECULAR ISOLATION, SOFT-LANDING AND CHARACTERIZATION USING STRUCTURES FOR LOSSLESS ION MANIPULATIONS

PROJECT SUMMARY/ABSTRACT (30 lines)
This project aims to address the current gap in technology for rapid and comprehensive (mass,
structure) profiling of biomacromolecules. While high resolution ion mobility and mass spectrometry
separations techniques have been extensively developed, their application has been largely limited to
small molecules (m/z < 2000). The ability to access structure and mass information in a high-throughput
fashion for macrobiomolecules is an aspirational goal in mass spectrometry. In pursuance of this goal,
we will develop a high-resolution ion mobility chemical analysis device based on Structures for Lossless
Ion Manipulations, and in conjunction with mass spectrometry obtain high-throughput high-resolution
IMS/MS of biomacromolecules. The study of the significant heterogeneity in large biomolecular
systems, i.e., macrobiomolecules, critical to biological research will be enabled by the development of
a new high resolution, high throughput analytical system. The SLIM platform, currently enabled for
ultra-high resolution ion mobility profiling (up to the point of separating isotopomers and isotopologues)
and manipulations of small molecular ions (<3000 Daltons) will be optimized to efficiently confine,
transport and separate macrobiomolecules. Initial optimization of the SLIM will be done by coupling
with a TOF-MS system. SLIM-TOF will be used to perform high resolution IMS/MS of ensembles of
macrobiomolecular species (with an upper mass limit of about 20,000 Da dictated by the TOF). We will
use SLIM-based IMS separations and other manipulations to reveal the extensive structural
heterogeneity of macrobiomolecules. Further, we will perform size and mass selective soft-landing of
macrobiomolecules using the dynamic switching and rerouting (to deposition substrates) of a selective
ion mobility distribution in the SLIM. The soft-landed species will be characterized using cryo-EM and
complimentary imaging techniques to elucidate the morphologies of macrobiomolecules with selected
mobilities or collision-cross-sections. The combination of ion mobility information and imaging will
provide a detailed structural characterization of macrobiomolecules.

Public health relevance
PROJECT NARRATIVE Structures for Lossless Ion Manipulations (SLIM) will be developed to enable biomacromolecule separations and coupled to a TOF-MS to perform high resolution IMS/MS of macrobiomolecules, selective rerouting of a portion of the ion mobility spectrum for soft-landing (to deposition substrates) and characterize the soft-landed species using orthogonal characterization techniques (e.g., cryoEM).